NUTRITION AND VIRAL/IMMUNE STATUS IN HIV INFECTED CHILDREN

The aim of this proposal is to determine whether early nutritional intervention will impace on immunologic and virologic markers of HIV infection in children. Study subjects will be HIV-infected children with poor growth. Subjects will receive enteral tube feeding, or standard clinical care with dietary counseling for 6 months. Analysis of CD4 and CD8 lymphocyte number, percentage of lymphoid cells with CD4 markers (CD 4%), CD4/CD8 ratio, HIV p24 antigen and quantitative PCR reactions for viral RNA and cDNA, serum neopterin and beta-2-microglobulin will be performed at baseline, 3 months, and 6 months. Growth and anthropometric measurements will be assessed monthly.